The Conformational Dynamics of eIF5B During Ribosomal Subunit Joining

ABSTRACT
Translation initiation in eukaryotes, which requires over a dozen eukaryotic initiation factors (eIFs), is a
highly regulated process that helps establish the fidelity of protein synthesis and is directly targeted during cellular
stress and disease. To add to the complexity of this process, ribosomal initiation complexes (ICs) undergo
multiple conformational rearrangements upon eIF binding and activity, and dysregulation of the associated
conformational changes are thought to underlie cellular stress and disease. Despite the importance of these
molecular rearrangements for the function of the translation machinery, current structural approaches cannot
resolve the real-time dynamics of the eIF binding events and IC structural rearrangements that are inferred from
comparisons of the static structural snapshots provided by X-ray crystallographic and cryogenic electron
microscopy studies. This presents a gap in our understanding of how eIF binding and eIF- and ribosome
structural rearrangements cooperatively ensure the fidelity of translation initiation. Specifically, the last step in
the initiation pathway, in which the large ribosomal subunit joins to the IC, functions as a final regulatory
checkpoint in the pathway. This step is regulated by the translational guanosine triphosphatase (GTPase) eIF
5B and eIF 1A. Specifically, 5B accelerates the subunit joining step in a GTP- and methionylated initiator tRNA
(Met-tRNAi)-dependent manner that is facilitated by 1A. This leads to questions such as: Do dynamic structural
rearrangements of 5B underlie its ability to accelerate subunit joining? If so, how do GTP and Met-tRNAi
modulate the dynamics of 5B? Likewise, how does 1A modulate the dynamics of 5B and how does such
modulation regulate the ability of 5B to recognize Met-tRNAi, accelerate subunit joining, and undergo GTP
hydrolysis upon subunit joining? To address these questions, I will use a combination of advanced single-
molecule Förster Resonance Energy Transfer (smFRET) techniques and ensemble biochemical and biophysical
approaches to characterize the dynamic structural rearrangements of 5B, 1A, and the IC during subunit joining,
and elucidate the contributions that these dynamics make to the mechanism and regulation of translation
initiation. The immediate goal of this proposal is to dissect the conformational dynamics and kinetics of 5B and
1A, demonstrating how these eIFs couple Met-tRNAi recognition to acceleration of subunit joining, GTP
hydrolysis by 5B, and dissociation of 5B and 1A following productive subunit joining.

Public health relevance
PROJECT NARRATIVE Translation initiation, which requires the action of over a dozen initiation factors, is the rate-limiting step in the process of protein synthesis that establishes the frame in which the messenger RNA will be translated and that is one of the major checkpoints that is directly targeted during cellular stress and disease. Ribosomal initiation complexes undergo intricate conformational rearrangements upon initiation factor binding, and dysregulation of these conformational changes often underlie the onset of cellular stress and disease. This application proposes an investigation of the compositional and conformational dynamics of eukaryotic translation initiation complexes during the ribosomal subunit joining step of the initiation pathway that forms the final point of regulation during translation initiation.